Abramson Cancer Center Support Grant

PROJECT SUMMARY/ABSTRACT Colorectal cancer is the 4th most common cancer diagnosed and the 2nd most common cause of cancer death in the United States. The age-adjusted incidence of CRC in Philadelphia County — a persistently high poverty area— is nearly 25% above the national average. Guideline-based screening for CRC via colonoscopy or fecal immunohistochemistry (FIT) reduces CRC-associated mortality. Despite the proven benefit of regular colonoscopy, CRC screening completion rates remain only around 50% in Philadelphia County and are consistently 10-15% lower for African-Americans than White individuals living in Philadelphia County. Adverse social determinants of health such as high poverty contribute to CRC screening nonadherence disproportionately for African-American and other minority communities. Recognizing this, in 2011, Penn Medicine created a navigation program to increase access to screening colonoscopies for patients in underserved areas of West, South, and Southwest Philadelphia by providing services that reduce barriers to cancer screening, including transportation assistance and detailed instructions on bowel prep. Despite initial success in increasing colonoscopies, a key challenge in scaling this navigation program is identifying patient populations at increased risk of CRC, who may benefit most from timely navigation. Automated machine learning (ML) algorithms based on routine electronic health record (EHR) data accurately estimate a patient’s relative risk of CRC. High-risk individuals may be particularly motivated to comply with disease screening recommendations and be targeted with an effective but resource-constrained navigator program. The overarching goals of this Administrative Supplement is to support the Abramson Cancer Center (ACC) mission to increase colorectal cancer (CRC) screening completion among high-risk individuals living in a persistent poverty county by designing, conducting, disseminating and evaluating an electronic health record- based automated identification program to target effective, culturally-sensitive CRC screening navigation to individuals who have not completed an ordered colonoscopy or fecal immunochemical test (FIT). Specifically, the goals of this supplement are to: 1) Adapt a previously validated EHR-based machine learning algorithm to predict CRC detection by retraining the model using data from patients seen in primary care clinics serving zip codes with a high proportion of racial and ethnic minorities living in Philadelphia County, a persistent poverty county; and 2) Implement and evaluate the feasibility and effectiveness of an algorithm-based CRC navigation program to increase colorectal cancer screening among 344 patients seen at one of 7 primary care practices within Philadelphia county who are at high risk of CRC, have uncompleted colonoscopies. Together, these projects aim to increase evidence-based screening in order to reduce the burden of CRC among high-risk individuals living in a persistent poverty county by utilizing evidence-based, targeted, culturally-sensitive CRC screening navigation that in part addresses social factors that prevent colorectal cancer screening.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because we aim to target an effective colorectal cancer screening initiative towards patients at risk for colorectal cancer who live in areas with persistent poverty, thus increasing guideline-based colorectal cancer screening for a high-risk population through targeted interventions to address social and clinical barriers to screening completion. This research proposal will optimize an automated machine learning algorithm to predict colorectal cancer risk using electronic health record data and an evidence-based navigation program to address poor colorectal cancer screening rates and increase access to screening colonoscopies for patients in underserved areas of West, South, and Southwest Philadelphia by providing services including transportation assistance, detailed instructions on bowel preparation, or mailed fecal immunochemistry tests. The project is relevant to the NCI’s mission by generating fundamental knowledge to inform clinicians, researchers, and policymakers about effective methods to utilize automated electronic health record interventions to increase the frequency and yield of guideline-based cancer screening in order to improve cancer associated outcomes among communities with high and persistent poverty.